Understanding the underlying relation between phonological clean-up ability and early word reading: A developmental exploration

PROJECT SUMMARY/ABSTRACT
It is estimated that approximately 3-10% of children experience significant and persistent word reading difficulties
(Fletcher, 2009). Despite decades of research devoted to reading, there are still many unknowns about the
underlying processes involved in word reading (WR) development in children, and more specifically the
assemblage of factors that lead to significant word reading failure (i.e., dyslexia). While there is broad consensus
that phonemic awareness (PA) and phonemic decoding (PD) skills are important underlying factors (particularly
in opaque alphabetic orthographies such as English) that support early WR skill and major determinants of early
failure, there is also an evolving realization that broader factors both within and outside the phonological
language domain are associated with WR failure. Thus, a deeper understanding of these broader phonological
factors/skills associated with word reading development is critical for advancing developmental WR theory and
the practical search for new predictors of early WR development that can help to improve on current inaccuracies
in the early identification and treatment of individuals who are at risk for word reading difficulty/dyslexia. Recent
studies in older readers (grades 2-5) suggest that development of word reading skill in English is heavily
dependent on a child’s ability to go from a decoded form of a word (derived during PD) to the stored phonological
representation, a phonologically based process we refer to as “phonological clean-up” (PC-U) skill and
operationalize with the “Set for Variability” mispronunciation task. Currently, it is unknown whether PC-U skill is
a precursor to skilled word reading or a consequence of exposure to text and instruction. This skill has not been
assessed in pre-readers nor has the longitudinal stability of its relationship with WR been assessed. The
purpose of this proposal is to examine the role of PC-U in supporting early WR development using a
longitudinal design in kindergarten-1st grade measuring each skill at the beginning and end of each grade
(i.e., 4 time points). Two specific aims are proposed. Aim 1 will explore the underlying mechanisms involved in
the relation between PC-U and WR skill. Using advanced statistical techniques we will explore the co-
developmental pattern between PC-U and WR examining whether causal links may be present in which level of
skill in one variable impacts growth in the other. We will further explore whether development is linked at the
word level such that the time a child learns to read a word is associated with PC-U performance on that word.
Aim 2 will explore the utility of PC-U as an identifier of risk for early WR difficulties. We will explore whether PC-
U performance at the fall of kindergarten contributes to the prediction of word reading at the end of 1st grade
after controlling for other kindergarten predictors known to predict word reading. Likewise, the importance of PC-
U in a classification tree predicting risk of word reading difficulties at the end of first grade using early kindergarten
predictors will be evaluated.

Public health relevance
PROJECT NARRATIVE Given the large number of individuals who experience word reading difficulties/dyslexia, there is a need to better understand the underlying processes that contribute to word reading development. Building a foundational understanding of the processes involved in word reading development will provide a basis for future research in the prevention and intervention of word reading difficulties. Furthermore, the addition of a strong and unique predictor of word reading may help improve early identification and screening practices for children at-risk for reading disabilities/dyslexia.